Optimization of an at-home continuous multi-domain monitoring and assessment system to improve Alzheimer's and related disorders clinical trials

Summary/Abstract: Alzheimer’s Disease and Alzheimer’s Disease-Related Dementias (AD/ADRD) adversely
impact our large and growing aging population. An estimated 5.8 million American’s 65 years and older are
suffering from AD, with that number projected to hit 13.8 million by 2050. Aging African American and Latinx
populations are particularly hard-hit by AD/ADRD, as are rural communities due to lack of access to clinical
trials and medical care. A broad range of symptoms are associated with these diseases and each patient’s
progression is unique and clinically quite variable. During a clinical trial, when longitudinal studies are
conducted over months to years, much of the patient’s lifestyle and function goes unmonitored as they are at
home with their partner or alone and without contact with professional providers. Infrequent data collection
relies on the ability of patients to accurately retrieve relevant details about their lives since the last checkup,
which is inherently inaccurate or incomplete due to the challenges of self-report and recall. Thus, there is a
critical need in clinical trials for more frequent, accurate, and complete patient monitoring especially in
communities that are currently underserved. To meet this need, Life Analytics is furthering the development of
an at-home monitoring platform, called Life Analytics Monitoring Platform (LAMP). LAMP is based off of the
NIH and VA funded Collaborative Aging Research Using Technology (CART) initiative system. CART is an
end-to-end (hardware and software) platform, which provides high-frequency monitoring of geriatric disease
progression by measuring real-world data, thus providing a digital remote assessment model to the academic
research community. The CART system was built by, and has been further developed by, our research team in
the Oregon Center for Aging and Technology (ORCATECH). Through these efforts a highly functional
generalizable infrastructure for support and deployment of these systems for academic research has been
established. To date, the ORCATECH/CART platform has been installed in more than 1000 homes across
North America and is currently collecting and transmitting data back to ORCATECH servers for analysis.
Additionally, the LA team has shown through publication that high-frequency in-home monitoring data allows
clinical studies to be appropriately powered with fewer patients. Therefore, this platform has the high potential
to change the way that clinical trials are conducted – if such a system can broadly disseminated. This Fastrack
will assist with the critical research and development required to improve the existing ORCATECH/CART
platform into the commercialized LAMP platform through the following Aims: SA 1 (Phase I): Migrate
ORCATECH/CART system to secure and scalable cloud operability. SA 2 (Phase II): Optimization of LAMP for
data transfer, storage, and analysis. SA 3 (Phase II): Demonstrate LAMP usability with Alpha-testing with a
third party, off-site location.

Public health relevance
Project Narrative: Alzheimer’s disease and Alzheimer’s disease-related dementia (AD/ADRD) are characterized by severe dementia that interferes with daily tasks, reduced memorization abilities, poor behavior, and inability to think clearly and afflicts nearly 6 million Americans 65 years and older. Clinical trials addressing AD/ADRD require large patient cohorts and are notorious for failures with over 400 unsuccessful attempts last decade. In this proposal, we further develop a non-invasive, at-home AD/ADRD patient monitoring platform that will provide continuous and quantitative measurements of health related biomarkers which in turn will improve the efficiency of clinical trials by providing high-frequency data to inform go/no-go decisions.